Phosphodiesterase inhibitors for Parkinson’s Disease therapy

SUMMARY
Parkinson's Disease (PD) is primarily characterized by motor impairment and nigrostriatal dopamine (DA) cell
loss. DA replacement with L-Dopa improve mobility initially, but long-term therapy is associated with motor
complications including L-Dopa-induced dyskinesias (LIDs). The major effect of DA replacement is the
modulation of activity of striatal projection neurons (SPNs). However, non-physiologic, chronic dopaminergic
stimulation is associated with maladaptive plasticity and altered SPN responses to DA inputs. DA signaling is
mediated by DA receptor activation and its effects on the synthesis of cAMP and cGMP. These nucleotides are
also regulated by their catabolic enzymes, the phosphodiesterases (PDEs). Therefore, PDEs may impact the
DA signals in SPNs after chronic L-Dopa treatment. This proposal will test the hypothesis that selective
phosphodiesterase inhibitors (PDE-Is) may improve motor responses to L-Dopa following chronic treatment. Our
hypothesis is based on differential distribution of PDE families in the brain and their specific substrate affinity.
These properties suggest that selective PDE-Is target particular cAMP and cGMP mechanisms in SPNs
subpopulations and induce specific motor effects. In this project, we plan to analyze the motor effects and
physiological striatal correlates of PDE-Is in animal models of PD.
Our research plan consists of two specific aims, each with two subaims, to determine behavioral and SPN
responses to selective PDE-Is combining primate and rodent models of PD. We will analyze motor and SPN
responses to L-Dopa under the effects of PDE-Is (PDE10A, PDE7B, and PDE9 inhibitors). These PDEs are
highly expressed in the striatum and have different substrate affinities (cAMP, cGMP, or both). We will use the
primate MPTP model of advanced PD for translatability of results. Hemiparkinsonian rats will also be used to
refine our cell resolution in the analysis of SPN responses. We will assess parkinsonian motor impairment and
LID with established methodologies, appropriate statistical power and rigorous experimental designs. We include
electrophysiology (single cell recordings), intracerebral injection of drugs, and calcium indicators (fiber
photometry) for analysis of SPN activity in vivo. We will also use transgenic models for assessment of responses
to PDE-Is specifically in direct and indirect SPNs. Results of these experiments will shed light on DA signaling
in SPN subpopulations, its regulation by PDEs, and associated motor effects of L-Dopa. Our long-term goal is
to translate our findings into a new therapeutic approach to reduce aberrant DA signals in SPNs, and improve
motor responses to L-Dopa therapy in PD. To this end, we expect to generate significant data with the proposed
novel studies of PDE function in PD models.

Public health relevance
PROJECT NARRATIVE Dopamine replacement with L-Dopa is the primary treatment of motor symptoms in Parkinson's Disease, but it loses efficacy over long-term therapy due to altered responses of the neurons in the striatum. This project will analyze the regulation of dopamine signaling mechanisms in the target striatal neurons that may be responsible for the chronic decay of L-Dopa therapy. Results of this study may help advance new treatments to restore adequate mobility in patients with advanced Parkinson's disease.